Alcohol, Gut derived inflammation, Disturbed Tryptophan Metabolism and CVD risk in People With HIV (GUT CVD HIV)

People living with HIV (PWH) have elevated risks of cardiovascular disease (CVD) ranging from myocardial
infarction to heart failure. Heavy alcohol use is a significant cardiovascular risk factor and is common among
PWH. Since, heavy alcohol drinking and HIV-1 infection are independently associated with the increased risk
of CVD, their interactive effects are likely to compound the risk and development of CVD. Indeed, work done
by our group has documented that heavy alcohol use is associated with higher CVD and total mortality rates in
PWH. However, there is limited understanding of the impact of interactive effects of heavy alcohol drinking and
HIV-1 infection on the development of CVD risk in PWH.
Our preliminary data and current evidence suggest that the gut derived inflammation and immune
activation fuels the abnormal immunometabolism of Tryptophan (TRP) leading to increased TRP catabolism
and the resultant biogenesis of inflammatory Kynurenine (KYN) pathway metabolites. These abnormal
changes in TRP catabolism have been implicated in the pathophysiological process of CVD. Importantly, work
done by our group and others have documented abnormal TRP catabolism in HIV infection and disease
progression in PWH; however, its relationship with CVD risk and CVD incidence, particularly in the context of
heavy alcohol use, remains largely unexplored. In relevance to the present studies, our preliminary data
demonstrates that abnormal increase in KYN/TRP ratio is directly associated with a higher proportion of CD4+
senescent T cells that play a pathogenic role in the vascular inflammation in atherosclerotic diseases. Thus,
our main hypothesis is that the interactive effects of alcohol and HIV-1 infection augment TRP catabolism with
resultant increase in the biosynthesis of inflammatory KYN and KYN/TRP ratio that in turn significantly leads to
the increase in CD4+ senescent T cells, vascular inflammation, and exacerbation of CVD in PWH.
To test this hypothesis, the proposed study leverages two existing and extremely well-phenotyped cohorts
from NIAAA funded studies on PWH with a history of heavy alcohol use - 1) Veterans Aging Cohort Study
(VACS) Biomarker Cohort and 2) Microbiome, Metabolites, and Alcohol in HIV to reduce CVD Randomized
Clinical Trial (META HIV CVD RCT) (P01AA029542 – Frieberg, Barve - MPI) with the following specific aims:
Aim 1: Determine if the dysregulation of Tryptophan (TRP) catabolism and generation of inflammatory
Kynurenine (KYN) pathway metabolites is associated with alcohol consumption and CVD in PWH. Aim 2:
Determine the effect of abnormal Tryptophan (TRP) catabolism, increased Kynurenine (KYN) levels and
KYN/TRP ratio on CD4+T cell subset distribution and induction of senescent T cells associated with CVD in
PWH with a history of heavy alcohol use. Aim3: Assess the impact of probiotic administration on increased
Tryptophan (TRP) catabolism and aberrant induction of senescent T cells associated with CVD in PWH with a
history of heavy alcohol use.